Clinical and Imaging Biomarker Trial of Uridine for Veterans with Suicidal Ideation

Veteran suicides, attempts and suicidal ideation (SI) remain of urgent concern to the Veterans Health
Administration (VHA). Recent reports indicate that approximately half of veteran suicides take place within 1
month of the decedent’s final VHA encounter, with one quarter occurring within 1 week. This provides a
temporal window of opportunity to intervene, and necessitates development of a rapid-acting treatment for
veterans with SI. Intravenous ketamine is the prototypical anti-suicidal drug, that rapidly reduces SI in some
patients. However, there are concerns regarding ketamine’s toxicity in both veterans, and military personnel.
These include ketamine’s potential for toxicity and misuse, and the brief duration of anti-suicidal effect. The
ideal VHA anti-suicidal treatment: 1) Could be administered orally rather than intravenously; 2) Would achieve
“target engagement” with the same neural substrates as ketamine; 3) Would have fewer risks; and 4) Would
have a longer duration of action and/or a more durable antisuicidal effect. Therefore this study will test the
novel intervention uridine as a rapid-acting oral treatment for veterans with SI. As described in the proposal,
uridine’s potential to fill this role lies in the broad overlap in the brain mechanisms and neural effects shared by
uridine, ketamine and the anti-suicidal drug lithium. The reason for this surprising commonality may lie in the
fact that ketamine’s mechanism-of-action dependent on activation of de novo pyrimidine biosynthesis – and the
fact that uridine is the endogenous circulating pyrimidine in man. To initiate testing of uridine for veterans with
SI, we will conduct a four-week, double-blind, placebo-controlled clinical trial of uridine 2000 mg daily for
veterans with SI. To make the study more informative, translational neuroimaging is integrated into the protocol
to identify biomarkers of SI. Veterans will undergo proton-1 magnetic resonance spectroscopy (1H-MRS)
imaging at baseline, with scans repeated after 1 week of treatment, in pursuit of a neurochemical biosignature
of rapid SI reduction. Upon completion of the four-week placebo-controlled phase, participants will enter the
six-month open-label phase of the study. The open-label phase will accomplish two goals: 1) To evaluate the
durability of uridine’s anti-suicidal effect in uridine responders; and 2) To ensure that veterans initially
randomized to placebo have a full and fair opportunity to benefit from active treatment. In summary, while
piloting a much-needed alternative to intravenous ketamine for suicidal veterans, this research also aims to
participate in establishing the neurochemical biomarkers of suicidal ideation, and treatment response.

Public health relevance
Veteran suicides, suicide attempts and suicidal ideation continue to be major public health concerns. This research addresses two critical unmet needs related to suicidal behavior among veterans: 1) The unmet need for a rapid-acting treatment for veterans who are experiencing suicidal thoughts; and 2) The unmet need for valid objective measurements, or biomarkers of veteran suicidality, to improve diagnosis and guide treatment development. Through pilot testing the novel anti-suicidal treatment uridine, while pairing it with brain scans performed before-and-after treatment, the goal of this study is to improve our understanding of suicidal ideation in the veteran population.